Physiological markers of listening effort and their dependence on age

Speech understanding is a key function of human audition with important roles in learning, professional, and
social functions. Ageing is associated with increased difficulties with speech recognition, particularly in noisy
backgrounds, although traditional clinical tests frequently fail to account for subjective speech perception
difficulties. A growing body of work has identified increased compensatory use of cognitive resources, collectively
known as listening effort (LE), as a key change within the ageing and hearing-impaired populations.
Consequently, accurate measures of LE may serve as critical objective diagnostic tools for quantifying subjective
speech perception deficits. While multiple methods for quantifying LE have been proposed, little is known about
whether these measures reflect usage of the same underlying cognitive processes, particularly in the context of
continuous speech in the presence of other meaningful speech maskers. Moreover, little is known about whether
changes in LE affect processing of lower- and higher-level features (e.g., acoustic envelope vs. lexical surprisal)
throughout the auditory cortical hierarchy. This proposal will address these important gaps in our knowledge. In
Aim 1, we will manipulate LE demands via changes in signal-to-noise ratio or spatial cues in a speech recognition
task utilizing isolated sentences masked by competing speech, while measuring three commonly used measures
of LE (self-report, pupil size, and neural measure of alpha band power). We will then correlate these measures
with one another to determine whether they are similarly modulated by intelligibility manipulations, indicating
common underlying cognitive processes. In Aim 2, we will address two key questions. First, we will test whether
the LE measures used in Aim 1 exhibit similar relationships with one another in the context of more naturalistic,
continuous speech, more closely mimicking scenarios in which speech perception difficulties are commonly
encountered. Second, we will use advanced model-based analyses to decompose speech-evoked
electroencephalographic activity into responses to lower- and higher-level features of both attended and ignored
speech and assess how LE manipulations modulate these representations. Doing so, we will gain novel insights
into the interaction between higher-order cognitive processes and the language processing pathways in the
cortex, potentially revealing new neural signatures of LE. Finally, to gain deeper understanding of aging effects
on LE and speech processing, we will assess how each Aim’s key measures change as a function of age. This
work will provide foundation for future studies aimed at a more detailed characterization of the effects of different
cognitive processes involved in LE on cortical processing of attended and ignored speech, with potential
applications in diagnostics of speech processing deficits, particularly in scenarios where standard clinical tests
fail to detect an impairment, and in testing speech-perception benefits from new algorithms used in hearing-
assisting devices.

Public health relevance
PROJECT NARRATIVE Age-related deficits in auditory processing are associated with increased reliance on listening effort in comprehension of speech in complex acoustic backgrounds. This research will provide insights about the effects of age on relationships between different measures of effort, and between effortful listening and neural representations of speech. These findings will be an important first step towards characterizing the role of different cognitive processes within the language processing hierarchy and may inform development of novel diagnostic measures for speech perception deficits that are missed by traditional clinical tests.